Sterol regulation of immunometabolic responses in cardiometabolic diseases

PROJECT SUMMARY
Alterations in the control of lipid homeostasis can lead to cardiometabolic diseases, including
atherosclerosis, the most common cause of mortality in Western societies. Cellular cholesterol homeostasis
significantly contributes to the chronic inflammation observed in atherosclerotic lesions, suggesting that the
immunometabolic modulation of pathological processes associated to atherosclerosis might represent the
next frontier in management cardiovascular diseases CVD).
Work from our laboratory has recently elucidated the key role of cholesterol biosynthetic
intermediates (desmosterol and lanosterol) and cholesterol derivatives [25-hydroxycholesterol (25-HC)] as
emergent immune regulators of macrophages in response to lipid overloading and innate immune
activation. Our preliminary data and previous studies demonstrated that desmosterol is the major ligand of
liver X receptor (LXR) in macrophages, modulating cholesterol metabolism and inflammatory responses in
foamy macrophages. Notably, macrophage overexpression of DHCR24, the enzyme that catalyses the
conversion of desmosterol to cholesterol, reduces cellular desmosterol levels and promotes atherosclerosis.
In this proposal, we will determine whether the genetic deletion of DHCR24 in macrophages attenuates the
progression of atherosclerosis and define the contribution of LXR in this process (Aim 1). We will test the
hypothesis that hepatocyte specific genetic deletion or pharmacological inhibition of DHCR24 will increase
circulating and vascular desmosterol levels, decreasing vascular inflammation and protecting against the
progression of atherosclerosis (Aim 2). These studies will exploit novel animal models allowing the
macrophages and hepatocyte genetic deletion of Dhcr24 and Lxrab and cutting-edge technologies
(genomics and metabolomics) to evaluate the potential therapeutic efficacy of increasing desmosterol levels
in macrophages for treating cardiometabolic diseases.

Public health relevance
PROJECT NARRATIVE Atherosclerosis underlies the leading cause of death in industrialized societies. Macrophages play a central role in the development of atherosclerotic cardiovascular disease by controlling vascular lipid homeostasis and innate and adaptive immune responses. This proposal aims to investigate the contribution of desmosterol, a cholesterol biosynthetic intermediate, in regulating macrophage immumometabolic responses. We will define how desmosterol produced by macrophages or delivered by the apo-B containing lipoproteins (chylomicrons, VLDL and LDL) contribute to vascular inflammation during the progression of atherosclerosis. Understanding the basis of metabolic reprograming of macrophage immune activation is anticipated to translate to new therapeutics opportunities to reduce residual inflammatory risk and cardiovascular disease.